Interrogation of the sRNA regulatory network mediating virulence of Streptococcus pneumoniae

Project Summary
Streptococcus pneumoniae is a leading cause of pneumonia, acute otitis media (ear infection), and
meningitis in the United States. S. pneumoniae remains an important pathogen despite a vaccine and
effective antibiotic treatments due to increasing levels of antibiotic resistance and vaccine evasion
through serotype switching. Virulence in S. pneumoniae is mediated by a complex gene regulatory
program that is only partially understood. In many bacteria, trans-acting small non-coding RNAs
(sRNAs) play key roles in regulating stress and virulence responses. While many sRNAs have been
identified in S. pneumoniae via high-throughput sequencing studies, biological function has been
assigned to only a few. The goal of this exploratory proposal is to identify the mRNA targets for sRNA
candidates in S. pneumoniae, focusing specifically on those implicated in mediating virulence. We have
two aims to reach this goal: First, we will determine the mRNA targets for a set of prioritized sRNA
candidates implicated in S. pneumoniae virulence during mouse infections. Second, we will
characterize the entire S. pneumoniae sRNA:mRNA interaction network. To achieve the first aim, we
will use MS2-afinity purification coupled with RNA sequencing (MAPS) to identify mRNA targets for a
set of prioritized sRNAs associated with fitness defects in mouse infections. MAPS tags each sRNA
individually to allow specific capture of sRNA targets, but allows unbiased identification of potential
mRNA partners via high-throughput sequencing of the captured RNAs. This approach will be combined
with computational tools that predict the targets of sRNAs using thermodynamic properties. A set of 5-
10 of the most promising mRNA targets identified from the combined approaches will be assessed
using reporter gene assays to validate the sRNA impact on gene expression. To achieve the second
aim, we will use RIL-seq, a technique which captures mRNA:sRNA pairing through crosslinking
followed by ligation. Subsequent sequencing identifies chimeric reads corresponding two interacting
RNAs. To enrich for sRNA:mRNA pairs, a FLAG-tagged RNA-binding protein partner to
immunoprecipitated the sRNAs. In S. pneumoniae, which lacks an RNA chaperone, we will use Cbf1,
an exonuclease shown to process sRNAs, to enrich our population. Taken together, our two aims will
identify mRNA targets for sRNA candidates associated with virulence, and move the field from
cataloging sRNA presence toward identification of sRNA biological function, and thus therapeutic
intervention.

Public health relevance
Project Narrative: Streptococcus pneumoniae is an important pathogen carried asymptomatically by a large proportion of the population that exhibits a transition to virulence characterized by a complex gene expression program. Small non-coding RNAs (sRNAs) are often critical mediators of virulence in bacteria, but are under characterized in S. pneumoniae. This research will identify mRNA targets for sRNAs necessary for virulence to illuminate the regulatory pathways leading to virulence.